Analysis of chronic muscle weakness in post-septic mice using a novel resuscitation protocol

? DESCRIPTION (provided by applicant): Sepsis is a severe life-threatening condition that damages multiple physiological systems which manifest in a devastating acute critical illness. After discharge from the hospital, 70-100% of severe sepsis survivors report sustained weakness which prevents them from resuming a normal lifestyle. As the mortality rate of sepsis declines due to advancements in critical care medicine and the incidence rate increases due to an aging US population, there are more than 1 million new sepsis survivors every year. It is predicted that the rate of sepsis survivors will continue to rise as the population ages and advancements continue to be made in treatment of sepsis. However, despite recognition of this clinical issue, the molecular mechanisms contributing to chronic muscle dysfunction after sepsis are not well understood due to the lack of an appropriate animal model. Current models are either too mild to induce muscle weakness or are too severe and cause death within a few days. To circumvent this problem, I developed a clinically relevant ICU-like sepsis resuscitation protocol with which 70% of middle-aged mice are rescued from otherwise completely lethal sepsis. The Aims of this project are (1) to test whether the mice that are rescued from lethal sepsis by the ICU-like resuscitation protocol exhibit muscle weakness, and (2) to identify the primary mechanism(s) responsible for muscle weakness after sepsis. Muscle functional analyses will be performed using in vivo and ex vivo strength tests at different time points after sepsis, which will be carefully designed so that the presence of atrophy and/or myopathy can be detected. I have already found that animals with lethal sepsis but rescued using my resuscitation protocol have significant muscle weakness 2 weeks after sepsis induction. Although the mechanisms by which sepsis-induced muscle weakness becomes a chronic condition are unknown, my preliminary data suggest that mitochondria are involved. Therefore, a series of molecular analyses will be performed to assess the time course and severity of muscle dysfunction and how it may cause reduction in force generating capacity by oxidizing sarcomeric proteins. These studies will promote the development of numerous scientific skill sets including proper animal research design, implementation, and interpretation as well as an assortment of molecular analysis techniques. Successful completion of this project will yield an understanding of the mechanism(s) responsible for muscle weakness after sepsis which could help elucidate a novel therapeutic target to prevent sepsis-mediated from developing in patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: For decades, sepsis survivors and physicians alike have reported muscle weakness that persists for years, but the lack of an appropriate animal model has been a critical barrier for identifying the underlying cause of this phenomenon. In this proposal, a newly optimized protocol that rescues animals from severe abdominal sepsis will be used to investigate muscle dysfunction in sepsis survivors. This will help to elucidate therapies for inhibiting the development of sepsis-mediated physical dysfunction, such as a mitochondria-targeted anti-oxidant.